EOB Clinical and Research Fellowship Training Program

The clinical and training fellowship program develops the expertise of trains in basic science, translational and clinical cancer research. The program is comprised of a multidisciplinary faculty; a curriculum tailored to the individual's career goals with the use of state-of-the-art research facilities. The fellowship trainees have a broad level of experience and trained in different specialties before entering the fellowship program. The participants in the fellowship program have successfully obtained academic, clinical and research positions.